Noncontact in vivo guidance of corneal collagen crosslinking therapy with optical coherence tomography and acoustic micro-tapping elastography

Abstract. Keratoconus (KC) is the most common and one of the most serious forms of corneal ectasia.
Corneal thinning and deformation of corneal geometry leads to its near-conical shape. Corneal shape and
thickness are currently used to characterize ecstatic changes, and Optical Coherence Tomography (OCT) is
the most accurate tool for that. Although corneal shape can be used to calculate refractive power, it cannot be
used alone to predict disease progression. In fact, elastic moduli changes in the cornea are a driver of ectasia.
Corneal collagen crosslinking (CXL) is a minimally invasive procedure that can potentially slow the progression
of ectasia [1-4]. UV light modifies the microstructure of cornea soaked in riboflavin and forms additional
chemical bonds between collagen fibers in the stroma leading to increased corneal stiffness. However, there
is currently no instrument that can provide noncontact, accurate assessment of corneal
anisotropic elastic
moduli. Indeed, the cornea is a bounded medium of highly organized collagen fibrils resulting in its highly
anisotropic mechanical behavior, requiring detailed techniques and models to map its elastic moduli.
The goal of this project is to develop a non-contact, non-invasive clinical tool based on Optical Coherence
Tomography and Elastography (OCE) to simultaneously map geometry (curvature and thickness) and image
elastic in- and out-of-plane mechanical moduli of cornea for longitudinal pre-and post-operative diagnostics of
KC progression and evaluate CXL surgery outcomes.
We hypothesize that quantifying corneal elasticity in vivo will enable significant innovation, providing a basis to
build an individualized biomechanical model of the eye, monitor progression of KC and other ectatic changes
in the cornea, guide customized treatment plans, and both predict and evaluate refractive surgery outcomes.
SA1 will focus on optimizing our unique AµT-OCE system for in vivo elasticity measurements in KC patients,
building it on a slit-lamp based platform and combining it with OCT topography. In SA2, we will map baseline
elastic properties in rabbit cornea pre- and post-CXL to confirm that elastic property changes due to the
procedure can be quantified. Leveraging the results of SA1, SA3 will focus on baseline moduli in healthy
volunteers matching the most likely demographic of KC patients to determine whether
moduli depend on race
and IOP
and define diagnostic criteria for KC. Finally, in SA4 we will perform cornea moduli mapping in KC
patients longitudinally pre- and post-CXL to comprehensively compare them to those in normal subjects.
This project builds on the rigor of our previous research where (i) we invented a fully non-contact system
to launch mechanical waves in the cornea and track their propagation with fast OCT [5, 6]. (ii) We showed that
the cornea is highly anisotropic and developed a proper model of corneal biomechanics [7, 8]. (iii) We tested
our approach in ex vivo and in vivo studies and validated our results with mechanical tests [7-10]. We also
obtained statistically significant preliminary data for CXL treated human cornea ex vivo [9].

Public health relevance
Narrative Corneal collagen crosslinking (CXL) is a cutting-edge therapy for progressive eye disease such as keratoconus, resulting in increased corneal stiffness; however, there are currently no non-contact techniques that quantitatively map corneal anisotropic elastic moduli, making it difficult to build personalized treatment plans and evaluate outcomes. Leveraging results obtained in R01 EY026532, the goal of this project is to develop a non-contact, non-invasive clinical instrument for pre-operative characterization and evaluation of post- operative outcomes in CXL treatment of keratoconus in the cornea based on Optical Coherence Tomography and Elastography. We will simultaneously map geometric (thickness and shape) and elastic properties of the cornea in vivo starting with a CXL rabbit model, continuing in healthy volunteers, and finishing in keratoconus patients pre-operatively, immediately after surgery and longitudinally post-operatively.